SF Bay Area MACS/WIHS Combined Cohort Study

This study complements the important ongoing MWCCS-wide COVID-19 study of vaccine hesitancy, compliance and uptake. Our mixed-methods approach (Aim 1) will leverage MWCCS core collection of vaccine uptake in order to establish temporal pathways and nuanced relationships between social position, medical mistrust, vaccine benefit mistrust, concerns about side effects, worries about corporate vaccine profiteering, and the preference for natural immunity. We will also build on existing core collection of general vaccine acceptance by 1) developing a new instrument assessing awareness of vaccine eligibility and access; 2) incorporating a vaccine communication instrument to better target messaging to high-risk populations; and 3) integrate a micronarrative component to explore in greater nuance individual-level factors that influence vaccine uptake decision-making, perceptions of vaccine communication strategies, vaccine distribution, and perceived vaccine hesitancy behaviors of the household and community. In addition, the data we propose to collect in the supplement could be leveraged after integration with COVID-19 core survey behavioral data to assess post- vaccine changes to COVID-19 prevention behaviors. This study will offer important insight into COVID-19 vaccine hesitancy and obstacles to vaccine acceptance, in addition to informing targeted communication strategies and intervention efforts that improve trust, increase uptake and break COVID-19 transmission dynamics among high-risk, aging populations with high comorbidity burden, exemplified in the MWCCS cohort.

Public health relevance
To date, there are only anecdotal data on COVID-19 vaccine acceptance and efficacy in people with HIV (PWH). The MWCCS is ideal for analyzing (a) the acceptancy and effects of COVID-19 vaccine(s) in male and female PWH and matched HIV-uninfected controls (HUC), (b) the impact of age and co-morbidities on vaccine immune response and protection against COVID-19, and (c) the social, economic, and behavioral changes after COVID-19 immunization as compared to the individuals who opted to not take the vaccine.